Characterization and Optimization of a Novel Bioreactor for Biomanufacturing and Cryopreservation

1 PROJECT SUMMARY
2 Organoids derived from stem cells are valuable tools that have potential to unlock cellular-based regenerative
3 medicine applications for otherwise incurable illness. Severe liver dysfunction, which affects millions of people
4 and is the 10th leading cause of death in the United States per year, can only be treated with a liver transplant,
5 but a critical shortage of organ donors means many patients die while on the transplant waiting list. Creating
6 functional and transplantable bioengineered liver tissue that can treat severe liver dysfunction would address a
7 critical unmet need in modern-day medicine. Achieving closed system operation and effective cryopreservation
8 in tissue culture are critical requirements for producing clinical grade bioengineered tissue that meets
9 regulatory requirements. With the goal of producing highly functional bioengineered liver tissue for cell-based
10 regenerative medicine applications, we developed a custom bioreactor to biomanufacturer induced pluripotent
11 stem cell (IPSC)-derived liver organoids in the simulated microgravity of low shear rotational suspension
12 culture. Our custom bioreactor, Tissue Orb, supports isochoric supercooling cryopreservation and is the
13 world’s first isochoric supercooling chamber that can support sterile tissue culture. Isochoric supercooling uses
14 constant volume to maintain aqueous solutions in a liquid state at sub-zero temperatures without the harmful
15 formation of ice. Importantly, the constant volume confinement has been shown to impart stability to the
16 supercooled condition, which decreases the need of toxic cryoprotectants that are required in other
17 cryopreservation methods. Furthermore, isochoric supercooling is simple to implement, involving a rigid
18 container with no moving parts, and was recently demonstrated to be a promising cryopreservation method
19 that can be easily translated to clinical or research settings to preserve biological material. Our lab is the first to
20 apply isochoric cryopreservation to liver organoids. We are now combining this technology with simulated
21 microgravity tissue culture in efforts to produce high quality liver organoids for regenerative medicine therapies.
22 The objective of this proposal is to improve isochoric supercooling protocols for liver organoids and complete
23 the design of the Tissue Orb to allow tissue culture and cryopreservation to occur in a single, closed system
24 and is a critical step towards achieving scalability and repeatability that is needed for high quality, clinical grade
25 products. We will expand on our prior work through a biological aim which looks to improve the protocol for
26 isochoric supercooling of liver organoids (Aim 1) and an engineering aim which looks to complete the design
27 for the heat exchange system to allow integrated isochoric supercooling in the Tissue Orb (Aim 2). The
28 proposed aims will result in information and technology that can lead to substantial improvements in our ability
29 to produce and preserve liver organoids, which, in turn, can drastically increase the availability of high-quality
30 bioengineered liver tissues to researchers and healthcare facilities around the world.

Public health relevance
PROJECT NARRATIVE Liver transplantation remains the only treatment for severe liver dysfunction—the 10th leading cause of death in the United States annually—but a critical shortage of organ donors severely limits how many patients can receive a transplant. The ability to bioengineer functional liver tissue to treat severe liver dysfunction can significantly decrease the problem of donor shortage and address a critical unmet need in modern-day medicine. By improving the ability of our customized technology to bioengineer and cryopreserve liver tissue, our proposed work could drastically increase the availability of bioengineered tissues to researchers and healthcare facilities around the world.